NICOTINE ABSTINENCE ON PHYSIOLOGICAL REGULATION OF THE HPA AXIS

The goal is to better understand the influence of gender on physiological processes relating hypothalamic-pituitary-adrencortical (HPA) axis activity in chronic smokers.